Structural mechanism of integrin-mediated TGF-b activation

Summary/Abstract: TGF-β drives the fibroinflammatory processes that leads to lung and airway fibrosis. The long-term goal of this project is to acquire a deep understanding of the regulation of TGF-β activity to develop new strategies and treatments for fibrosing lung disease. There are few effective therapies to treat chronic fibrosing and inflammatory diseases of the lung. The cytokine TGF-β is a central mediator of fibrosis and pathologic inflammation and is a potential therapeutic target in fibrosing lung disease. However, the practical utility of targeting TGF-β itself or its receptors is limited by risk of toxicities seen in rodents, primates and humans. More specific methods to target the fibroinflammatory effects of TGF-β are highly desirable. A promising method to more specifically target local effects of TGF-β is to target its “activation” since it is always produced in a latent form (L-TGF-β) that must be activated in order to function. Another feature of L-TGF-β that could facilitate more specific targeting is that it is covalently bound to specific cell surfaces by GARP. L-TGF-β binding to the integrin αvβ8 is essential for TGF-β activation in vivo. For the αvβ8 activation mechanism, as well as all others, it has long been assumed that TGF-β must be released from LAP so that free TGF-β can diffuse and bind its receptors on target cells. Based on recent structural data obtained using single particle electron cryomicroscopy (cryo-EM), we have recently proposed a new model whereby αvβ8 can bind to L- TGF-β on cells presenting the L-TGF-β/GARP complex and induce signaling without release and diffusion of TGF-β. Here in three aims, we address three critical questions concerning this new model of L-TGF-β activation. (1) Which flexible domains of L-TGF-β of the αvβ8/L-TGF-β/GARP ternary complex shield TGF-β from its receptors? (2) Is flexibility of L-TGF-β induced by binding to αvβ8 necessary to mediate TGF-β activation? (3) Do TGF-β receptors (TGF-βRs) bind to TGF-β within the αvβ8/L-TGF-β/GARP complex? To answer these questions, we will use cryo-EM to determine the structure of the αvβ8/L-TGF-β/GARP complex to determine how flexibility of L-TGF-β contributes to TGF-β activation, and finally we will capture the multimeric complex of TGF-βRs with αvβ8/LTGF-β/GARP. These studies will improve mechanistic understanding of TGF-β activation and therapeutic targeting strategies to inhibit it.

Public health relevance
Narrative: There are currently few to no effective therapies to treat the airway and lung fibrosis in chronic obstructive pulmonary disease (COPD) and pulmonary fibrosis. The multifunctional cytokine transforming growth factor- (TGF-) is at the apex of a series of pathologic inflammatory and fibrotic events that culminate in fibroinflammatory pathology. The far-reaching goals of this project are to improve mechanistic understanding so that TGF- can be effectively and selectively targeted to treat fibrosing and chronic inflammatory lung disease.